Research Training in Infectious Diseases

The objective of this program is to train physician-scientists in basic, translational, and clinical
biomedical research focusing on infectious diseases. The training program will use the
resources of 3 allied institutions, co-located on the east side of Manhattan in New York City:
Weill Cornell Medicine will be the primary institution with collaborators at Rockefeller University
and Sloan-Kettering Cancer Institute. The program’s faculty are well-funded scientists with
independent research support who are committed to research and training. They are
complemented by 3 international collaborators from Brazil and Haiti. The faculty share the view
that the physician-scientist truly is an endangered species and are committed to address this
issue by establishing long-term mentoring relationships with postdoctoral trainees.
The broad areas of research training are: immunology, malaria, mycobacteriology, virology, and
translational/clinical research, including bacterial and fungal infectious diseases of global
importance, and HIV/AIDS. Trainees and mentors will develop an individual development plan
(IDP) that can include, for example, additional formal courses in the Weill Cornell Graduate
School (e.g. immunology, molecular biology) or enrollment in a K30 Master’s in Clinical
Investigation program.
During the funding period (1999-2024), 58 trainees were appointed and 53 (100%) completed
their training (5 continue in the program). Twenty-seven (51%) of 53 who completed the
program received NIH K Awards and two are reapplying. Research subject areas included:
drug-resistant bacteria, HCV, HIV, KSV-HHV8, malaria, schistosomiasis, and tuberculosis. A
total of 70% hold current appointments at academic institutions and 79% currently conduct
research. In total, 26 (49%) of T32 trainees completing the program were women, 10 (19%)
were racial/ethnic minorities, and 2 were from disadvantaged backgrounds.
The program will continue to recruit physicians who have completed their clinical training
(medicine, pediatrics, pathology) and are seeking academic investigative careers as physician-
scientists. This training grant will provide developing physician-scientists with the opportunity to
make the transition from clinical training to research. We request to maintain 5 training slots a
year for a training period of 2-3 years.

Public health relevance
This training program will provide physician-scientists with the mentoring and skills needed to embark on successful careers conducting research in infectious diseases of public health importance in the Unites States and worldwide. The training will focus on HIV, malaria, drug- resistant bacteria, tuberculosis and other diseases of global importance.